The Experimental Tobacco Marketplace (ETM)

SUMMARY/ ABSTRACT
Project 3's long-term objectives are to understand the substitutability between novel and more frequently used
tobacco products, the factors promoting and mitigating illegal tobacco purchases, and the generality of these
findings in diverse non-laboratory samples in different types of users. Project 3's aims are 1) to compare the
substitution between different tobacco/nicotine products as a function of tobacco-user type, 2) to model policies
that may promote and mitigate illegal tobacco purchases for different types of tobacco users, and 3) to
examine the generality of laboratory-based findings and their moderators using diverse samples (US, England,
and Canada) from the International Tobacco Control Policy Evaluation Project. Participants will be both
exclusive cigarette smokers and dual cigarette/nicotine vaping product users because these individuals are
most at risk for negative health outcomes associated with combusted tobacco. The methods will employ the
Experimental Tobacco Marketplace (ETM), an online purchasing experience that places a mix of products,
prices, and specific regulations under experimental conditions that simulate “real world” circumstances. The
ETM provides estimates of the effects of product changes and/or policy changes on tobacco purchasing
patterns, including between-product substitution in different types of tobacco product users. Here the ETM will
be used to examine the effects of novel products, such as heated tobacco and nicotine pouch products, on
purchasing patterns and the uptake of different products (substitution). Further, the Illegal Experimental
Tobacco Marketplace (iETM), a methodological extension of the ETM, was developed to examine conditions
that promote or mitigate against illegal purchases. Here the iETM will be used to examine the effects of
regulatory environments that tend to promote illegal purchases, such as high cigarette prices and reduced
nicotine content cigarettes. Moreover, this project will examine policy strategies that may mitigate illegal
purchases, such as health communications, availability of nicotine replacement therapy, and penalties. The
ultimate health impact of this project is to inform tobacco regulation, reduce tobacco-related harm, and improve
public health.

Public health relevance
NARRATIVE The tobacco landscape has changed significantly in terms of products and policy response, with the response to those policies potentially engendering illegal tobacco purchases. This project will experimentally examine the effects of tobacco marketplace expansion (e.g., novel tobacco/nicotine products), new potential policies (e.g., reduced nicotine content) that may result in illegal purchasing, and strategies to decrease illegal purchases (i.e.., health communications, availability of nicotine replacement therapy, and penalties) among diverse users across different countries. The ultimate goal of this project is to inform tobacco regulation, reduce tobacco-related harm, and improve public health.